Inductively Coupled Plasma Mass Spectrometer

Abstract
We request funds for a new inductively coupled plasma mass spectrometer (ICP-MS) interfaced to a ultra-
performance liquid chromatography (UPLC) system and a laser ablation (LA) system to be located at the Institute
for Innovation in Imaging at Massachusetts General Hospital (MGH). ICP-MS is a powerful analytical tool for the
detection and quantification of trace elements in a broad range of sample types and is widely accepted as the
method of choice for elemental analysis. Modern instrumentation can analyze up to 60 elements simultaneously
with a dynamic range spanning 9 orders of magnitude from parts per trillion to parts per thousand. A UPLC
interface enables speciation of metal or metalloid analytes in complex matrices like blood plasma or tissue
homogenate with fast analysis times. Additionally, a laser ablation interface allows multi-elemental analysis
directly off a surface, such as a microscope slide, enabling low micron spatial resolution. There is an existing
HPLC-ICP-MS funded by a prior Shared Instrument Grant that is extensively used by numerous investigators at
MGH and outside. However, that instrument is 8 years old, increasingly in need of repair and does not provide
the UPLC or LA capabilities that users desire.
The dual mission of the Institute for Innovation in Imaging is technology development and translational
research involving advanced imaging techniques such as magnetic resonance imaging (MRI), positron emission
tomography, optical imaging, and ultrasound. Accurate elemental analysis underpins much of this work. For
instance, in molecular imaging probe development, quantitative elemental analysis is used to characterize the
probes, quantify their distribution, pharmacokinetics, and metabolism in tissue. For imaging of metal ion
homeostasis, ICP-MS provides a crucial gold standard. Development of metal-based therapeutics benefits
tremendously from UPLC-ICP-MS for metabolism studies and from LA-ICP-MS for mechanism of action studies.
Contrast agents are widely used in the development of quantitative in vivo imaging techniques, e.g. perfusion,
permeability, blood volume measurements; ex vivo elemental analysis of these contrast agents can serve to
calibrate and validate these methodologies.
The requested instrumentation will be administered as a shared resource for the Institute for Innovation in
Imaging, the larger MGH research community, as well as other institutions in the greater Boston area. The
Principle Investigator and Advisory Committee will ensure both equitable and cost-effective operation of this
system. The acquisition of this UPLC-ICP-MS with laser ablation will greatly benefit our research community
and we expect it will play an essential role in driving many new discoveries pertaining to a host of medically
related issues including cancers, lung diseases, skeletal disorders, immunology, neurological diseases, heart
diseases, liver diseases, stroke, and neural plasticity.

Public health relevance
Project Narrative Funds are requested to replace an existing shared ICP-MS instrument for elemental analysis that will allow quantification and distribution of metals and metalloids in biological tissue. The analyses enabled by this instrument will underpin NIH-funded research projects in cancer, heart disease, neurological diseases, skeletal disorders, immunology, chronic liver disease, stroke, neural plasticity, and lung disease.